CHANGES IN THE RBC PROTEOME DURING HEALTH AND DISEASE

DESCRIPTION (provided by applicant): Changes in the RBC proteome during health and disease Abstract: Recent studies of the red blood cell (RBC) proteome have yielded extensive lists of both membrane and soluble proteins. While these catalogs of RBC proteins are quite impressive, they contain little if any quantitative information. The analysis of differential protein expression can be crucial for the discovery and understanding of the biological underpinnings of disease, as well as for providing novel biomarkers for diagnosis or prognosis, for assessing risk profiles and outcomes, and for identifying novel targets for individualized treatment. Within the last few years there have been significant advances in mass spectrometry and software for the quantitative, comparative analysis of complex mixtures of peptides. We hypothesize that the global quantitative expression patterns of proteins in RBC will reflect differences that exist in normal live but also those that occur due to disease. Here we propose to develop a robust, label-free proteomics platform for defining differential protein expression in RBCs. We will assess the level of technical variation, as well as define variations due to inter-individual and gender differences. We will then test the platform developed and apply it to define the differences in global protein expression patterns in two classic red blood cell disorders, Paroxysmal Nocturnal Hemoglobinuria (PNH) and Diamond Blackfan Anemia (DBA). Finally, we will use the platform developed and the signature proteins that define the disease to monitor the changes that occur in the RBC proteome during disease specific treatment. Our findings are likely to provide new insights into the pathophysiology of these diseases, and might lead to the identification of novel markers, or to the discovery of new targets for the development of diagnostic tests or drugs. Furthermore, the tools we develop should prove broadly applicable to the quantitative comparison of RBC membrane proteomes of varying physiological or disease states.

Public health relevance
PUBLIC HEALTH RELEVANCE: We hypothesize that the global quantitative expression patterns of red cell proteins will reflect normal physiological variations, as well as variations that occur during disease. In this grant we propose to develop a robust, label-free proteomics platform for defining differential protein expression in red blood cells. We will assess the level of technical variation associated with the platform and define variations due to normal physiological differences. We will then test the developed platform by applying it to define the differences in global protein expression patterns that occur in two classic red blood cell disorders, namely Paroxysmal Nocturnal Hemoglobinuria (PNH) and Diamond Blackfan Anemia (DBA). Our investigations are likely to provide new insights into the pathophysiology of these diseases, and might lead to the identification of novel markers, or to the discovery of new targets for the development of diagnostic tests or drugs. Furthermore, the platform we develop should prove broadly applicable to the quantitative comparison of RBC proteomes of varying physiological or disease states. We hypothesize that the global quantitative expression patterns of red cell proteins will reflect normal physiological variations, as well as variations that occur during disease. In this grant we propose to develop a robust, label-free proteomics platform for defining differential protein expression in red blood cells. We will assess the level of technical variation associated with the platform and define variations due to normal physiological differences. We will then test the developed platform by applying it to define the differences in global protein expression patterns that occur in two classic red blood cell disorders, namely Paroxysmal Nocturnal Hemoglobinuria (PNH) and Diamond Blackfan Anemia (DBA). Our investigations are likely to provide new insights into the pathophysiology of these diseases, and might lead to the identification of novel markers, or to the discovery of new targets for the development of diagnostic tests or drugs. Furthermore, the platform we develop should prove broadly applicable to the quantitative comparison of RBC proteomes of varying physiological or disease states. __SpecificAimsTextDelimiter__ A. Specific Aims This grant is submitted in response to the program announcement from the NIDDK "Erythroid Lineage Molecular Toolbox (PA-07-011)" to stimulate research in erythroid cells. Recent studies of the red blood cell (RBC) proteome have yielded extensive lists of both membrane and soluble proteins. While these catalogs of RBC proteins are highly impressive, they provide little if any quantitative information. The analysis of differential protein expression can be crucial for the discovery and understanding of the biological underpinnings of disease, as well as for providing novel biomarkers for diagnosis or prognosis, for assessing risk profiles and outcomes, and for identifying novel targets for individualized treatment. Within the last few years there have been significant advances in mass spectrometry and data processing for the quantitative, comparative analysis of complex mixtures of peptides. We hypothesize that the global quantitative expression patterns of proteins in RBCs reflect normal physiological variations, as well as variations that occur during disease. Here we propose to develop a robust, label-free proteomics platform for defining differential protein expression in RBCs. We will first assess the level of technical variation associated with the platform, and define variations due to normal physiological differences. We will then test the developed platform by applying it to define the differences in global protein expression patterns in two classic red blood cell disorders, namely Paroxysmal Nocturnal Hemoglobinuria (PNH) and Diamond Blackfan Anemia (DBA). Finally we will use the platform to monitor the changes that occur in the RBC proteome during disease specific treatments for PNH and DBA. Our investigations are likely to provide new tools to gain novel insights into the pathophysiology of these diseases, and might lead to the identification of novel markers, or to the discovery of new targets for the development of diagnostic tests or drugs. Furthermore, the platform we develop should prove broadly applicable to the quantitative comparison of RBC proteomes of varying physiological or disease states. The specific aims of the proposed research are: Aim 1. To develop a label-free comparative proteomics platform for the reproducible detection of differential protein expression in RBCs. The aim of this goal is to use multi-dimensional, rapid-acquisition, high-accuracy mass spectrometry (nano-capillary liquid chromatography coupled to a linear quadrupole ion trap Fourier transform ion cyclotron mass spectrometer (nano-LC-LTQ-FT-MS)) or on our newly-installed LTQ- ORBITRAP. Computational analysis of the MS data will be accomplished using peak alignment/detection software (Rosetta Elucidator") for high-density proteomics data. Statistical analysis will be performed using our new, nested variance model that measures and partitions biological and analytical variation associated with sample procurement, preparation and peptide ion currents from LC-MS. Using this platform, we have already developed reproducible methods for the purification and proteomic analysis of RBC membranes. We have examined technical variation at the levels of membrane and peptide preparations, as well as run-to-run instrument variability. We will next assess variations in protein expression profiles due to inter-individual differences (female vs. female, male vs. male), gender differences (female vs. male). "Targeted" mass spectrometry (MS) will be used to determine the sequences of differentially expressed peptides and the corresponding protein identities. Mass spectrometry is performed in collaboration with the Proteomics Core Facility and the Bioinformatics Core of the Siteman Cancer Center at Washington University. Aim 2. To apply the developed platform in order to identify the differences in global protein expression patterns between RBCs from normal individuals and those from patients with PNH; and to determine the changes occurring in the RBC proteome during eculizumab therapy. PNH is an acquired hemolytic anemia caused by increased sensitivity of RBCs to complement-mediated lysis. The goal of this aim is to apply the platform developed in Aim 1 to determine the protein signature that characterizes the PNH RBC. For this analysis, the RBC proteomes from 10 PNH patients will be compared to 10 age-, race-, and gender-matched control individuals. Computational and statistical analysis of differentially expressed proteins will enable us to propose testable hypotheses, which will be investigated experimentally. We will then use the platform to identify changes that occur in the PNH RBC proteome in patients receiving eculizumab, an inhibitor of the C5 component of complement. The eculizumab studies will be performed longitudinally, with analyses of RBC proteomes from 10 patients prior to treatment, and 6 and 12 months into treatment. We will monitor the changes that occur in global protein expression patterns during this time. In addition, we will use targeted MS analysis to specifically monitor changes that occur in the identified PNH signature proteins. Aim 3. To apply the developed platform in order to identify the differences in global protein expression patterns between RBCs from normal individuals and those from patients with DBA; and to determine the changes occurring in the RBC proteome during treatment with steroids. DBA is an inherited red cell aplasia. The goal of this aim is apply the tools developed in Aim 1 to characterize differences between the protein expression profiles of RBCs from DBA patients and those from normal individuals. For this analysis, the RBC proteomes from 10 DBA patients will be compared to 10 age-, race-, and gender-matched healthy control individuals. Computational and statistical analysis of differentially expressed proteins will enable us to propose testable hypotheses which will be investigated experimentally. We will then monitor changes that occur in the DBA RBC proteome in patients initiated on steroid treatment. This study will be performed longitudinally, with analysis of RBCs from 10 DBA patients prior to and during steroid treatment at the established maintenance dose for at least 3 months. In addition, we will use targeted MS/MS analysis to specifically monitor changes that occur in the identified DBA signature proteins. We will monitor the global protein expression changes that occur, as well as the changes that occur to the identified signature proteins using targeted MS/MS analysis.